The Misdiagnosis of Speech Sound Disorders in Spanish-speaking Preschoolers Acquiring African American English

Project Summary/Abstract According to the the Rehabilitation Act of 1973, Section 504, every child is entitled to a free and appropriate public education; however, that is not always the case for many African American and Latino children. Children from under-represented backgrounds are often misdiagnosed with speech sound disorders due to limited research and training in linguistic diversity (American Speech-Language-Hearing Association, 2017). When children are misdiagnosed with speech sound disorders, they receive therapy services they do not need. As a result, linguistically diverse children are pulled out of their classrooms and miss general education curriculum. Not only does it waste taxpayers’ dollars, it results in the under-education of a large segment of our student population. Misdiagnosis of speech sound disorders occurs when speech-language pathologists do not have the right evaluation tools to accurately diagnose children who speak a dialect of English that is unfamiliar to them. Therefore, this research will (1) develop a theoretical model that predicts the language change that occurs when different dialects come in contact with one another and (2) document the dialect of English that emerges when African American and Latino children live and go to school together in order to develop accurate diagnostic criteria for speakers of this dialect. Speech samples from African American and Latino children will be transcribed and analyzed for production patterns. By comparing these children’s speech production to that of their peers who speak Standard American English on current standard measures of speech sound ability, I will not only be able to characterize typical speech and disordered speech in speakers of this dialect, but develop the diagnostic criteria that speech-language pathologists need to make accurate diagnoses and prevent children from missing out on the education they deserve. This fellowship includes mentorship and training opportunities with an interdisciplinary team of researchers across the country, including the two data collection regions - Tucson, Arizona and Raleigh-Durham, North Carolina. The training goals for this fellowship include training in statistics and phonetics software programs as well as training in the development of diagnostic assessment protocols.

Public health relevance
Project Narrative This research addresses the health and educational disparities faced by African American and Latino children that result from the misdiagnosis of speech sound disorders. The long-term goal of this research is to develop diagnostic criteria that can be easily and accurately utilized by speech-language pathologists who do not speak the dialect of children they assess.